Enhancing OK-INBRE Research Partnerships with COBRE Programs in Oklahoma

Multimodal Neuroimaging Assessment and Rehabilitation of Cognitive Impairment in Brain Tumor
ABSTRACT
Cognitive impairment is highly prevalent in up to 90% of patients with brain tumor at varying pre- or post-
surgery points in the disease course. Surgical resection can alleviate some of these neurocognitive symptoms,
but can also cause additional symptoms if critical brain regions or pathways are damaged during surgery.
Moreover, cognitive impairment is not only seen in brain tumor, but also in many other cancer types and even
as a common adverse outcome in chemo-therapy treatment. Currently, there are no clear guidelines on how to
rehabilitate these patients with cognitive impairment. Transcranial magnetic stimulation is a well-established
rehabilitation technique in motor and language recovery, and more recently a promising technique for cognitive
function, especially in combination with brain imaging. The long-term goal of the project is to establish the
mechanism and rehabilitation pathway of cognitive impairment in patients with brain tumor. This proposal for a
collaborative Administrative Supplement assembles a research team of OK-INBRE investigator Dr. Nesreen
Alsbou at University of Central Oklahoma and COBRE P20GM135009 research project leader Dr. Han Yuan at
The University of Oklahoma, which is aligned with OK-INBRE goals by providing support for these early-stage
investigators to build on a nascent collaboration that is in its early stages. To ultimately enable a TMS-based
cognitive rehibition technique, the current project will establish a perturbation-based imaging protocol based on
the novel multimodal system of concurrent transcranial magnetic stimulation and functional near-infrared
spectroscopy made available via previous COBRE and INBRE support, and extend the research domain to the
eminent issue of cognitive function in brain tumor that is beyond the already establish rehabilitation pathways
regarding motor or language functions. Especially, developing this supplement collaborative project can mutually
benefit the INBRE and COBRE investigators by sharing novel research ideas and imaging tools in two
complimentary aims. In Aim 1, the research team will establish the novel multimodal imaging protocol and
determine the signal response associated with the enhanced cognitive performance. In Aim 2, a novel algorithm
for reconstruction-based motion correction will be developed, which will have the potentials to transform the
signal-to-noise ratio. If successful, this supplement collaborative project will open new opportunity to assemble
the existing and complimentary research resources to empower novel research ideas, which can ultimately
improve patient outcome in brain tumor and other cancers and also will provide more research opportunities to
the undergraduate students in both University of Oklahoma and University of Central Oklahoma.

Public health relevance
PROJECT NARRATIVE: The objective of this proposal is to develop a multimodal neuroimaging based strategy for to identifying and rehabilitating cognitive impairment in patients with brain tumor. The novel imaging and reconstruction algorithms developed in the project will have the potentials to tailor a safe treatment to be more precise and effective in individual patients. Success of this project will be able to enhance the impaired working memory functions in patients with brain tumor or other cancer types.